RegulomeDB: A Resource for the Human Regulome

PROJECT SUMMARY
The Human RegulomeDB project provides an essential resource that facilitates medical
research and exploratory investigations of gene regulation. The majority of sequence variation
identified in genome sequencing projects and disease association studies (GWAS) lie within the
98% of the human genome that is non-exomic. RegulomeDB is a unique web accessible
resource that provides integrated knowledge of the wealth of existing information concerning
regulatory elements that lie within non-exomic regions. The unique feature of this resource is its
ability to comprehensively annotate, integrate and display the experimentally defined functional
and biochemical regulatory elements of the human genome. Information generated from
individual laboratories and consortia concerning potential regulatory regions such as that
affecting gene expression, transcription factor binding, chromatin modification and DNA
methylation will be collected from the literature, and integrated into a common database and
displayed at nucleotide resolution. The information can be readily accessed via a web
accessible interface and related to sequence variations identified from large scale projects (e.g.
db SNPs, 1000 genome project, GWAS studies). Researchers will be able to compare variants
identified from personal genomes and large scale sequencing projects as well as GWAS studies
to the wealth of information in RegulomeDB, and thereby rapidly gain knowledge of non-exomic
information. Given the wealth of DNA sequencing project that are emerging, we expect this
unique resource to have wide impact in the biomedical community.

Public health relevance
RELEVANCE TO PUBLIC HEALTH, PROJECT NARRATIVE The regulation of gene expression controls the determination of cell types, and aberrant gene expression can cause diseases such as cancer. RegulomeDB will enable researchers, clinicians, and sophisticated computer programs to relate DNA variants that lie in previously poorly understood regions of the human genome to possible functions thereby helping us understand the genetic basis of human variation and disease.